FGFR1-NCAM Interactions Promote Neuron-Mediated Outgrowth of ER+ Breast Cancer Brain Metastasis

Abstract
Brain metastasis (BM) confers the worst survival outcomes for patients with breast cancer (BC). While most
breast cancer brain metastasis (BCBM) research focuses on triple-negative and HER2+ subtypes, which have
higher rates of BM, estrogen receptor positive (ER+) breast cancer, the most frequently diagnosed subtype,
accounts for a large fraction of BCBM. Aside from being severely understudied, ER+ BCBM occurs in the unique
clinical setting of age and low estrogen (E2). Preliminary data from our lab demonstrates that while models of
ER+ BCBM in young mice require supplementation of E2, as is the standard across the field, BCBM were able
to outgrow independent of E2 supplementation in older mice, suggesting that the aged brain provides a distinct
niche that supports E2-independent outgrowth of ER+ BCBM. Prior studies have identified FGFR1 aberrations
as drivers of endocrine resistance and predictors of increased risk for BCBM. Published and preliminary studies
show that FGFR1-amplification alone is not sufficient to drive tumor progression in post-menopausal mouse
models; rather, FGFR1-kinase signaling activation through the microenvironment promotes tumor progression
under low E2. Our preliminary studies show that ER+ patient-derived xenografts (PDX) with FGFR1-amplification
have greater ability to colonize the brain, and FGFR1 downregulation decreased the ability of FGFR1+ ER+ BC
cells to grow in organotypic brain slices and in the brain in vivo, suggesting that brain-induced activation of
FGFR1 may play a role in the promotion of ER+ BCBM. Recent studies have shown that growth of BCBM cells
depends on their ability to form pseudo-synapses with glutamatergic neurons, and that neuronal activity can
drive BM outgrowth of multiple cancers. Binding of FGFR1 to NCAM (neural cell adhesion molecule) promotes
synaptic plasticity and activates FGFR1 downstream signaling in neurons. Our preliminary studies indicate that
treatment of ER+ BC with exogenous NCAM induces rapid kinase and downstream oncogenic pathway
activation, and that FGFR1 downregulation reduces synapse density in ER+ BC cells co-cultured with brain
slices. Thus, the hypothesis of this proposal is that that FGFR1 contributes to ER+ BCBM in the aged and E2-
depleted brain microenvironment by i) binding to neuronal NCAM and activating downstream oncogenic signaling
and ii) promoting neuronal activity-mediated signaling in ER+ BM. Aim1 will define how interactions between
FGFR1 in ER+ BC and NCAM in neurons promote cancer growth downstream of FGFR1. Aim 2 will determine
the impact of FGFR1 on the functionality of synapses between ER+ BC and neurons. The long-term goal of this
proposal is to study novel interactions between ER+ BC and neurons through FGFR1. This study will identify
how FGFR1 in ER+ BC promotes BM outgrowth through neuronal-specific interactions, providing insight into
drivers of ER+ BCBM that can inform future therapies and clinical biomarkers.

Public health relevance
Project Narrative Brain metastasis from ER+ breast cancer is often lethal, affects many patients, and is severely understudied. This proposal will explore how FGFR1 in ER+ breast cancer underlies specific interactions with neurons to drive outgrowth of brain metastases. The results of these studies will inform novel, potentially targetable pathways of ER+ breast cancer brain metastasis progression in the clinically relevant setting of age and low estrogen.